Training In Systems And Integrative Biology Neuroscience

This is a competing renewal of a five-year Institutional NRSA application for the support of predoctoral
students in the interdepartmental Graduate Program in Neuroscience at Emory University. A fundamental
strength of this program is the broad interdisciplinary training provided in a wide spectrum of neurobiological
issues spanning several basic and clinical neuroscience-related disciplines. Because of the significant growth
in highly qualified applicants to this program during the past funding period and the high success rate of
current trainees in building up an outstanding record of peer-reviewed publications and successfully
competing for external funds at the national level (among the top 4 neuroscience programs for NRSAs at the
national level), we seek support for 10 students per year in this renewal (ie 3 more than the current funding
state). A total of 81 PhD students (+ 17 new recruits for fall 2020) are enrolled in this program, which has
consistently attracted a large and very high quality applicant pool from all over US and a significant number
of international applicants with outstanding academic credentials. The program has been extremely
successful in enrolling outstanding underrepresented minority (URM) students during the past 5 years, and
in attracting a larger pool of highly qualified URM to apply. Over 25% of the current pool of students in the
program and trainees supported by this training grant are from URM ethnic groups, a 65% increase from the
previous renewal application. Over 90% of trainees who have been supported by this training grant for the
past ten years have successfully developed research-related careers. The attrition rate of the program has
been below 10% for the past ten years. An Executive Committee representing the 130 (94 on this grant)
faculty from 22 departments and the Yerkes National Primate Research Center administers the program. This
committee is headed by the Director, who oversees all aspects of program operation, two Directors of
Graduate Studies, who monitor student progress, and the Director of Admissions, who is in charge of
recruitment of new students in the program. Students in the program receive a broad curriculum of molecular,
cellular and systems neuroscience courses in their first two years. A required hypothesis design and grant
writing course helps students prepare their thesis proposal (with oral defense) in the form of an NRSA
predoctoral fellowship application. Training in quantitative literacy, scientific rigor and reproducibility has been
integrated in these core courses. Trainees are also required to participate in 3 laboratory rotations before they
pick their advisor (usually at the beginning of year 2). A wide variety of elective courses ranging from Basic
Mechanisms of Neurological Diseases, Brain imaging, Computational Neuroscience and Neuropharmacology
are available to advanced trainees. Finally, students actively participate in various seminar series and receive
significant training in teaching, neuroethics and scholar integrity. The quality of the Neuroscience program
and the progress made under this training grant are evaluated by an external advisory board every 2-3 years.

Public health relevance
This proposal is a competing renewal application to support the training of 10 pre-doctoral students enrolled in the PhD graduate neuroscience program at Emory University during years 1 or 2 of training. The interdisciplinary Emory neuroscience program currently comprises a total of 94 training faculty and 81 PhD students involved in neuroscience research that cuts across a wide array of disciplines that range from the understanding of basic neural communication to the treatment of complex neurological and psychiatric disorders. The dramatic growth of the applicant pool, combined with the large number of well-funded neuroscience faculty and excellent achievements of the current trainees in producing solid peer-reviewed publications, seeking external grants and developing highly successful research-related careers, serve as the main basis to justify the request of a raise in the number of slots supported by this training grant from 7 to 10 for the next funding period.